Discovery and development of novel HCMV inhibitors

ABSTRACT
Infection with human Cytomegalovirus (HCMV) is nearly universal; seroprevalence rates reach 90% in
individuals older than 80. Although usually asymptomatic in the normal host, HCMV causes severe morbidity
and mortality in transplant recipients and patients with AIDS. Congenital HCMV is the leading infectious cause
of childhood deafness and mental retardation. There is no approved vaccine for the prevention of HCMV. The
nucleoside analog ganciclovir (GCV) and its oral formulation val-GCV have improved the outcome of
transplantation. GCV may also prevent hearing deterioration in congenitally infected children. However,
prolonged courses of GCV or val-GCV result in intolerable toxicities to the bone marrow and select for resistant
viral strains. The alternative drugs for GCV-resistant HCMV, foscarnet, and cidofovir, also target the viral DNA
polymerase. Both are nephrotoxic agents and can only be administered intravenously. The HCMV UL97 kinase
inhibitor, maribavir, was recently approved for adults and children (> 12 years of age) with resistant/refractory
HCMV disease, and the terminase inhibitor, letermovir, is approved for HCMV prophylaxis after hematopoietic
stem cell transplantation. Resistance has already been reported to these two new agents. The limited HCMV
therapeutic armamentarium and the emergence of drug-resistant mutants create an urgent need to identify
new HCMV inhibitors with a novel mechanism of action. Our goal is to develop a new class of HCMV inhibitors
that act through a novel viral target(s), the helicase-primase (H/P). As a prototype, compound MLS8091
inhibits HCMV, including GCV-resistant strains, and we have identified that resistance to MLSS8091 resides in
the primase and primase-associated factor of the H/P complex. The following Specific Aims are proposed in
this R01: 1) Delineate the mechanism(s) of action of MLS8091. 2) Define the interactions and activities within
the H/P complex. 3) Design and synthesize MLS8091 analogs to identify a lead compound for in vivo studies.
Our program is innovative and highly significant because the target for HCMV inhibition is novel and critical for
virus replication, we already identified resistant mutants, and we assembled a multi-disciplinary investigative
team to develop inhibitors of the H/P complex. Our team has combined expertise in virology, proteomics,
structural biology, biophysics, biochemistry, and chemistry. At the end of the project, we expect to: 1) Confirm
the HCMV H/P as a druggable target, 2) Provide purified proteins, biophysical and enzymatic data of the H/P
complex for future HCMV drug discovery, and 3) Identify the most favorable small molecule HCMV inhibitor(s)
through drug design and synthesis.

Public health relevance
PROJECT NARRATIVE Human Cytomegalovirus (HCMV) causes serious morbidity and mortality in solid organ and bone marrow transplant recipients and is the most common congenital infection worldwide. Treatment options for HCMV are extremely limited; therefore, new therapeutic strategies against HCMV are urgently needed. The overall aims of this proposal are to develop new inhibitors of HCMV that target the helicase primase complex.